TESTING OF NON-STEROIDAL MALE CONTRACEPTIVE AGENTS

Type Justification: This contract program requires the initiative of NICHD staff to undertake its execution The synthesis program and the biological testing of the proposed compounds require extensive and active participation of and coordination by the NICHD staff. This consists of: 1) monitoring the progress of the work and the purity of the compounds being tested, 2) testing the compounds in the CRHB's biological testing facility